TREATMENT OF CYSTINURIA WITH BUCILLAMINE

The overall goal of this project is to prove that Rimatil (on weight basis) is more effective that Thiola in lowering systine excretion, and that it provides a greater safety of usage in patients with cystinuria.